Investigating the epigenetics of enhancer function in Cancer

Project Summary/Abstract: Mono-methylation of histone 3 lysine 4 (H3K4me1) is a chromatin mark closely associated with transcriptional enhancers and other intergenic regulatory elements; however, the functional significance of this histone modification has yet to be demonstrated. Our lab has previously identified Trr and MLL3/4 as the major H3K4- monomethylases in Drosophila and mammals, respectively. Recent genome-wide association studies identified the trr human orthologues, MLL3 and MLL4, as genes frequently mutated in a wide variety of human cancers, along with other COMPASS subunits. Previous work has established that Trr protein is necessary for regulating enhancer function; however, the role of Trr-dependent H3K4me1 at enhancers has not been tested directly. To address this, we have taken advantage of an embryonic recessive lethal Trr-NULL allele, trr[1], to test the necessity of Trr-dependent methylase activity. We have found the trr[1] lethality can be rescued by expressing a Trr transgene whose SET domain contains either a catalytic-inactive (C2398A) or a catalytic- hyperactive (Y2383F) point mutation. As expected, western blots confirm substantial reductions of H3K4me1 in the catalytic-dead mutant, while the catalytic-hyperactive mutation shows significant increases in H3K4me2/3. Our ChIP-seq studies verify these changes are occurring specifically at enhancer elements. Aside from these molecular phenotypes, the two mutant fly lines show no obvious developmental, reproductive, or behavioral differences in comparison with a control trr-WT rescue line. These observations raise three important questions: 1) what is the function of Trr-dependent H3K4-methylation in Drosophila development, 2) what are the non-enzymatic functions of Trr in regulating enhancer-mediated processes, and 3) how do non- catalytic mutations found in MLL3/4 disrupt enhancer function and lead to human cancer pathogenesis? By exploiting Drosophila melanogaster, in which MLL3/4 are represented by just one enzyme, trr, I will uncover fundamental details regarding how these proteins function to regulate enhancer activity, and how deleterious mutations to MLL3/4 result in cancer formation.

Public health relevance
Project Narrative: Intergenic H3K4me1, deposited by the Trr enzyme, is an epigenetic mark closely associated with enhancer sequences and transcription factor binding sites; however, the precise molecular function of this particular histone modification remains elusive. We demonstrate that, while Trr protein is absolutely necessary, its catalytic-activity is dispensable for Drosophila development and viability. This is an unexpected finding, considering the high degree of SET-domain sequence homology among the COMPASS family of H3K4- methylases, and deserves further investigation to better understand the true biological function of H3K4- monomethylation and the enzymes that catalyze it.